Generation of DNA memory by bacterial CRISPR-Cas9 systems

Project Summary
Prokaryotes have evolved a myriad of defense systems to protect themselves from viruses (i.e., bacteriophages)
and other parasitic elements. Uniquely among these, CRISPR-Cas enables adaptive immunity through RNA-
programmed destruction of the invader genome. During infection, bacteria can capture viral DNA snippets into
their CRISPR loci as immune memories (termed spacers), in a process known as spacer acquisition or CRISPR
adaptation. CRISPR RNAs transcribed from this memory will then guide Cas enzymes to locate and degrade
complementary targets in the invader to achieve immunity. Much progress has been made in understanding the
Cas enzymes and their applications in genetic engineering. However, how microbes acquire CRISPR memories
from viruses remains poorly understood.
Our research programs aim to decipher the molecular basis of viral memory acquisition in CRISPR-Cas9 and
unveil the contributions of bacterial host gene networks to this mysterious phenomenon. We also thrive to
uncover novel mechanisms by which bacteriophages evade CRISPR-Cas9 immunity. Gram-negative pathogen
Neisseria meningitidis (Nme) and its cryptic inoviruses (i.e., filamentous phages) serve as our model systems.
We recently found a novel role of guide-less apoCas9 in regulating spacer acquisition and safeguarding immunity
depth in meningococci. In the next five years, we will use bacteria genetic, deep sequencing, bioinformatic, and
biochemical approaches to tackle outstanding questions, including: How does Cas9 coordinate with the Cas1-
Cas2 integrase mechanistically to regulate acquisition? What host factors play key roles during viral spacer
acquisition, and how? What diverse anti-defense approaches have Neisseria phages evolved to counteract
CRISPR-Cas9 and CRISPR-Cas3 immunity?
This proposed research will generate new insights into CRISPR-Cas adaptability. This work will also illuminate
the co-evolutionary arms between pathogenic bacteria, their CRISPR-Cas, and viral predators. Moreover,
findings from our research promises to guide technology advances, including phage-encoded CRISPR inhibitors
for controlling genome editing applications to improve safety, and Cas9-Cas1-Cas2 based genome-tagging and
molecular recording devices.

Public health relevance
Project Narrative Prokaryotic CRISPR-Cas systems enable adaptive immunity against viral infections, and nowadays also provide eukaryotic gene-editing tools that revolutionized the study and treatment of human diseases. In this proposal, we aim to uncover the molecule basis for CRISPR-Cas9 antiviral immune memory formation and their evasion by viruses. This work will substantially advance our understanding of the evolutionary arm race between bacteria and their phages and help guide the expansion of CRISPR-based technologies to benefit human health.